A SYSTEMS THEORY APPROACH TO THE STUDY OF COLON AND LUNG CANCER HEALTH DISPARITIES USING NOVEL DATA LINKAGES

Abstract
We will conduct innovative linkages between our state cancer registry, all-payer claims data, and mental health
treatment sources from the South Carolina Integrated Data Warehouse to create a population-based, diverse
cohort of cancer patients (including < 65 years of age) that will allow us to comprehensively examine
disparities in novel targeted therapies, the joint and individual effects of treatment and co-morbidities, and
multi-level contributors across multiple domains to cancer survival trajectories. While we have made significant
improvements in cancer prevention and control since the 1950’s, we have failed in our attempts to narrow the
gap of cancer disparities experienced by minority and rural peoples. In our state with higher African American
(AAs; 28%) and rural (34%) representation, we have previously documented excess mortality of 60 to 75% for
African Americans (AA) compared to whites. Furthermore, a comprehensive (including diagnosis and all
treatment courses) and national cancer surveillance system that includes younger cancer survivors (< 65 years
of age) is completely impossible in our current cancer registry infrastructure. Consequently, the goal of this
investigation is to examine novel targeted therapies, effects of co-morbidities, and modifiable, multi-level
contributors to AA treatment outcomes, survival trajectories, and disparities. To achieve this goal, we propose
the following specific aims: 1) describe and compare patterns of novel targeted therapies for lung and colon
cancer by race, socioeconomic status, and urban/rural designation and their impact on survival disparities, 2)
describe and compare the individual and joint effects of cancer treatment and outcomes for concurrent co-
morbid diseases (CVD, diabetes, depression, and opioid use disorder) in a population-based cohort of lung
and colon cancer survivors by race, socioeconomic status, and urban/rural designation and their impact on
survival trajectories, 3) applying geospatial approaches within the context of NIMHD’s Research Framework for
minority health, to examine multi-level and system-level contributors (biological, behavioral, socio-cultural,
environmental, physical environment, and health systems) to racial, socio-economic, and rural survival
disparities for lung and colon cancer survivors to identify modifiable targets for intervention, and 4) disseminate
and translate our research findings into multiple levels of cancer care and among a diverse community of
stakeholders. Through the extensive networks and community partners previously established by this
outstanding, inter-disciplinary research team, we will partner with our community advisory panel to interpret
and disseminate these findings throughout professional and lay communities in order to identify targets for
future intervention at the individual, community, and policy level. The SC-Midlands Chapter of the American
Cancer Society and South Carolina Cancer Alliance will be key partners in our dissemination efforts. In this
way, our application is poised to make a significant impact on cancer health disparities.

Public health relevance
A SYSTEMS THEORY APPROACH TO THE STUDY OF COLON AND LUNG CANCER HEALTH DISPARITIES USING NOVEL DATA LINKAGES Project narrative/relevance African Americans and rural Americans are disproportionately affected by both cancer incidence and mortality with little progress made in narrowing the gap with their white or urban counterparts. With this application, we will combine unique data sources to create a population-based, racially, socio-economically, and geographically (urban versus rural) diverse cohort of men and women to examine targeted therapies, comorbidities, and multi-level contributors to survival disparities for colon and lung cancers. We will convene an advisory board of community leaders, organizations, and clinicians to identify multi-level and modifiable targets for intervention.